Smartphone-Based Diabetes Prevention in the VA: A Cluster-Randomized Trial

PROJECT SUMMARY Type 2 diabetes (T2D) affects 26 million Americans and “pre-diabetes” affects 86 million more. If this epidemic is not addressed immediately, 23% of Americans will have T2D by 2030. Current lifestyle programs to prevent diabetes are complex to deliver, costly, and have limited scalability. Medications do not clearly modify the disease process and have a number of side effects. New approaches are needed that can address this epidemic on a population scale. mHealth technologies (e.g., smartphones) are deeply integrated into our lives and can target the daily lifestyle behaviors that underpin the T2D epidemic. The Veterans Health Administration (VHA) is an ideal setting to test mHealth approaches because they are at the forefront of harnessing smartphone technologies to deliver care with the advent of the “VA App Store.” As the nation's largest integrated healthcare system, VHA has a central dissemination infrastructure to deliver smartphone interventions to over 5.5 million Veterans. Our team has developed BeWell24, an adaptive and multicomponent smartphone “app” that was developed based on the unique needs and desires of US Veterans and VHA clinical teams. BeWell24 targets behaviors across the 24 hours — sleep, sedentary behavior, and more active behaviors — and our preliminary data suggest reductions in fasting glucose among prediabetics of 12.3% in just 8 weeks of use. We are adding a dietary component to the app to further enhance the potency of the intervention. Our objective now is to test whether the delivery and integration of this app into routine clinical care settings can improve glycemic control over 12 months. We propose a rigorous cluster- randomized trial, randomizing 14 patient-aligned care teams (or “PACT teams”) to deliver the app or usual care to at-risk patients (total N=280 Veterans). Our first aim is to test whether BeWell24 significantly improves glycemic control (reduce fasting glucose and HbA1c) over 12 months relative to usual care. We will further explore objectively-measured changes is targeted behaviors (sleep, sedentary behavior, physical activity, and dietary intake) and other key cardiometabolic biomarkers (weight/body fat, blood pressure, lipids, insulin, and hs- CRP). Our second and third aims are to assess factors impacting scalability of BeWell24 from patient and provider perspectives to optimize opportunities for large-scale dissemination if efficacious. We will monitor program reach/retention, app usage, treatment acceptability, program costs, and clinical integration factors. Unique features of this proposal are the rigorous cluster-randomized design; testing in a highly integrated, nationwide, clinical setting; and use of a highly sophisticated smartphone platform uniquely designed for the population and targets multiple health behaviors impacting T2D risk. The long-term goal is to establish an effective diabetes prevention program among Veterans that can be used to complement and enhance existing clinical support. If effective, this approach could be rapidly scaled to Veterans nationwide and could have broad applicability for other populations at disparate T2D risk as well as other disorders.

Public health relevance
PROJECT NARRATIVE Type 2 diabetes (T2D) is a national epidemic and current lifestyle programs and medications are not effectively managing the crisis. This project aims to test a novel smartphone-delivered intervention that simultaneously targets multiple health behaviors (i.e., sleep, sedentary behavior, physical activity, dietary intake) within clinical settings at a large Veteran Health Administration regional hospital. If effective, this project has potential for large-scale implementation nationwide through the VA healthcare system and broad applicability for other populations at T2D risk as well as other disorders.